PATHOPHYSIOLOGY AND MANAGEMENT OF PITUITARY TUMORS

This study assesses pathophysiologic mechanism in patients with functioning pituitary tumors, especially prolactinoma and growth hormone secreting adenomas. Studies include measurements of somatomedins and growth hormone by a variety of assays. Further, through systematic followup of these patients who are admitted primarily for studies of pathophysiologic mechanisms, we will assess the efficacy of therapy.